Addressing alcohol misuse in HIV prevention and care: The Brown University Alcohol Research Center on HIV (ARCH)

Overall Project Summary
Alcohol misuse impacts the depth and breadth of the HIV epidemic, both domestically and globally, through
multiple pathways—increasing sexual risk behaviors, reducing adherence to antiretroviral therapy, and
increasing the risk for HIV-associated comorbidities and mortality. To reduce the incidence of HIV, approaches
must be developed that concurrently address alcohol misuse in the context of HIV testing and behavioral and
biomedical prevention approaches. Likewise, to increase rates of HIV viral suppression and reduce HIV-related
comorbidities, alcohol misuse must be addressed effectively in diverse populations across a spectrum of HIV
care settings. The Brown University Alcohol Research Center on HIV (ARCH) has been supporting
collaborative research to develop scalable alcohol-HIV interventions, including video counseling, telehealth,
and web-enabled applications, that can be delivered broadly and efficiently using centralized personnel and
technological resources. This application to renew the Brown ARCH is organized around the central theme that
in order to achieve population impact, interventions addressing alcohol misuse in HIV prevention and care
need to be evaluated with an emphasis on real-world effectiveness, scalability, and sustainability, according to
the principles of implementation science. Specifically, we propose three projects that leverage our unique
strengths in (a) training professionals in alcohol misuse interventions, (b) utilizing video counseling and
telehealth as scalable means of reaching populations and providing continuing care, and (c) utilizing behavioral
intervention technologies to provide alcohol interventions and ongoing support for change. Research
Component 1 (MPI: Wray and Monti) extends our work on the role of alcohol use in HIV transmission among
men who have sex with men (MSM) by testing the effectiveness of a web-based intervention that addresses
both alcohol use and sex risk in MSM completing HIV self-testing. Research Component 2 (PI: Kahler) extends
our work on behavioral telehealth interventions to reduce alcohol misuse in HIV-infected MSM by testing our
previously developed video counseling and text messaging interventions in a diverse sample of patients in HIV
care at four large, urban federally-qualified health centers. Research Components 1 and 2 share a Hybrid Type
1 effectiveness-implementation trial design, providing data on real-world effectiveness while gathering data
related to implementation to inform future studies. Research Component 3 (MPI: Becker and Kuo)
complements these projects by conducting an implementation trial that evaluates a cascading training model to
promote alcohol screening and brief intervention across HIV care settings in South Africa. Together, these
projects—supported by an Administrative Core, Research Methods Core, and Program Advisory Committee
and complemented by an outstanding training program in alcohol-HIV research with robust pilot funding
opportunities—will make a substantial impact in translating basic and applied knowledge on alcohol and HIV
into scalable approaches to reducing the negative impact of alcohol misuse on HIV prevention and care.

Public health relevance
Overall Project Narrative Alcohol misuse has broad effects on the HIV epidemic, both domestically and globally, contributing to HIV transmission and poor outcomes for those in HIV care. The proposed renewal of the Brown University Alcohol Research Center on HIV (ARCH) will support collaborative research to evaluate the most effective ways to address alcohol misuse in HIV prevention and care through the use of novel HIV staff training models and technology-assisted interventions. Results of ARCH research will directly inform approaches to reduce the substantial social and health costs associated with the co-occurrence of alcohol misuse and HIV.